Examining the Integration of Hospitals, Public Health, and Social Services to Target the Social Determinants of Health Using Patient-Centered and Comparative Effectiveness Research Methods

Abstract
This is an application for a K01 award for Dr. Rachel Hogg, an Assistant Professor at the University Of
Kentucky College Of Health Sciences. Dr. Hogg is establishing herself as a young investigator who uses
Patient Centered Outcomes Research (PCOR) and Comparative Effectiveness Research (CER) methods to
examine the effect models of clinical and community collaboration around the health-related social
determinants of health have on improved health care quality and reduced hospitalizations and readmissions.
This K01 award will provide Dr. Hogg with the support necessary to achieve the following goals: (1) develop
expert knowledge in the types of models being used to integrate clinical and community organizations to
address not only health care, but also the health-related social determinants of health, (2) establish herself as
an independent researcher with mastery of using advanced Comparative Effectiveness Research methods to
determine effect heterogeneity in how clinical-community models address diverse population needs, and (3) To
secure R01 level funding using the Public Health and Social Service Sensitive Admission Measures as an
outcome. Dr. Hogg has assembled a mentoring team comprised of primary mentor, Dr. Glen Mays, and Co-
Mentors, Drs. Patrick Kitzman, Danielle Varda, and Mark Williams.
Addressing the health-related social determinants of health has emerged as a leading strategy to
combat the increasing economic and financial burden of preventable hospitalizations and readmissions. Dr.
Hogg’s study will use a mixed methods approach to examine in greater detail the models being used across
the US to integrate public health and social services with clinical care provided in hospitals as a mechanism to
target the social, behavioral, and environmental factors that contribute to hospitalizations and readmissions
(Aims 1 and 2). Dr. Hogg’s project will also engage patients, caregivers, and community stakeholders to
determine the extent to which patient, caregiver, and provider experiences with health care are influenced by
the surrounding delivery systems for public health and social services (Aim 3). The findings will cumulate in a
template model that will be proposed for pilot testing as part of a R01 application to be submitted before the
end of the K award.

Public health relevance
Project Narrative This study has the potential to reveal how health care system organization and delivery policies can be used to improve health and lower health care costs across the US by examining the benefits of integration between hospitals and other community organizations to address patient needs. Results have the potential of leading to beneficial changes in policy at the local, state, and federal level that impact individual health. The value of the knowledge to be gained from this research is considerable given its potential health and economic implications on a broad, population-wide basis.